Effects of Early Life Exposure to Household Air Pollution on DNA Methylation and Respiratory Disease in Guatemalan Children from the Household Air Pollution Intervention Network (HAPIN) Trial

PROJECT SUMMARY
Household air pollution (HAP) from solid fuel use causes an estimated 400,000 chronic obstructive pulmonary
(COPD) deaths each year. Although lung function and lower respiratory disease in childhood are determinants of
COPD risk later in life, there are few studies of the influence of early life HAP exposure on respiratory health later
in childhood. We propose a HAP study design that is sensitive to emerging chronic respiratory effects by
incorporating three key features: 1) assessment of exposure during early life windows of susceptibility, 2) a strong
exposure contrast introduced by a randomized intervention, and 3) sensitive endpoints that predict chronic
disease later in life. Gestation and infancy are critical windows of susceptibility due to the rapid lung development.
Previous HAP intervention trials had only low to moderate effectiveness for reducing HAP exposure. The
Household Air Pollution Intervention Network (HAPIN) trial (2017-2021) offers a time-sensitive, unique research
opportunity because the liquefied petroleum gas (LPG) stove and fuel intervention lowered median gestational
fine particulate matter (PM2.5) exposure in Guatemalan participants by 77%, from 98 to 23 µg/m3. The intervention
continued until age 1 year and extensive health data were collected, including pneumonia incidence and severity.
We have maintained follow-up of the cohort post-intervention, assessing HAP exposure and child growth at age 2
years plus lung function at age 3 years. We posit that childhood lung function and lower respiratory disease
episodes are sensitive indicators of HAP health effects that relate to adulthood COPD. DNA methylation (DNAm)
and pneumonia during infancy may influence these respiratory endpoints later in childhood. We propose to
leverage our successful LPG cooking intervention in Guatemala to investigate effects of early life HAP exposure
on longer-term respiratory health and explore DNAm as a biomarker. We hypothesize that the randomized LPG
cooking intervention and lower PM2.5 and black carbon (BC) exposure will be associated with DNAm at age 1 year
and greater lung function and fewer lower respiratory disease episodes at age 4-7 years. Aim 1. Estimate effects
of a randomized LPG cooking intervention during gestation and infancy (age <1 year) (Aim 1.A) and HAP
exposure (PM2.5 and BC) during and after the intervention (Aim1.B) on lung function trajectories (age 3-7 years)
and lower respiratory disease incidence (ages of 4 to 7 years). Aim 2. Estimate effects of a randomized LPG
cooking intervention (Aim 2.A) and HAP exposure (Aim 2.B) during gestation and early infancy (age <1 year)
on DNAm biomarkers at the end of the intervention period (age 1 year). Aim 3. Determine whether DNAm at age
1 year (Aim3.A) and pneumonia episodes until age 1 year (Aim 3.B) are associated with lung function
trajectories and lower respiratory disease incidence between ages of 3 to 7 years. Effects of early life HAP on
lung function and lower respiratory disease later in childhood would have important implications for the early life
origins of COPD in populations exposed to HAP, and identifying epigenetic changes that might underpin this
relationship could lead to improved research and interventions.

Public health relevance
NARRATIVE Household air pollution resulting from cooking with solid fuels (wood, charcoal, animal dung, coal), the primary household energy source for nearly 3 billion people, is responsible for an estimated 2.3 million premature deaths each year, primarily in low- and middle-income countries. The proposed work leverages the Household Air Pollution Intervention Network (HAPIN) trial in Guatemala to evaluate whether a liquefied petroleum gas (LPG) stove and fuel intervention to reduce this harmful exposure during early life (pregnancy and infancy) improves children’s lung function development and reduces respiratory disease episodes beyond the intervention period and until age 7 years, while exploring epigenetic biomarkers as research tools to understand the biological mechanism of effect. The proposed work will impact health and household energy policies by providing rigorous and generalizable insight to questions regarding the impact of air pollution exposure in early life on respiratory health later in childhood using a scalable household intervention.